Whole genome sequencing for outbreak investigations of foodborne pathogens and antimicrobial resistance studies for FDA Vet-LIRN

FDA CVM Vet-LIRN PROGRAM GRANT PROPOSAL
FOR FOA # PAR-18-604
“Vet-LIRN Network Capacity-Building Projects”
ABSTRACT
This grant proposal from the Ohio Department of Agriculture (ODA) is in response to
Funding Opportunity Announcement (FOA) # PAR-18-604 from the Food and Drug
Administration’s (FDA) Center for Veterinary Medicine (CVM) Office of Research
Veterinary Laboratory Investigation and Response Network (Vet-LIRN). The project is
titled “Whole genome sequencing for outbreak investigations of foodborne pathogens and
antimicrobial resistance studies for FDA Vet-LIRN”.
This proposal from ODA’s Animal Disease Diagnostic Laboratory (ADDL) addresses the
following key project areas:
1. Increasing the capacity of laboratories conducting pathogen susceptibility testing
by funding the updating or purchasing of additional equipment.
2. Procurement of supplies needed for AMR testing efforts or method improvement.
3. Purchase of liquid handling system for handling of samples for Vet-LIRN foodborne
pathogen case investigations.
4. Conduct increased testing in response to a new need identified by the VPO.
5. Participation in multi-laboratory blinded tests to validate newly developed Vet-LIRN
Network methods.
The ADDL is also poised to address new developments in emerging regulatory sciences
as well as urgent or novel areas for potential research. Several additional documents
including the internal Proficiency Testing (PT) results (appendix of Research Plan), and
certificate of AAVLD accreditation (appendix of Research Plan) are provided along with
the

Public health relevance
FDA CVM Vet-LIRN PROGRAM GRANT PROPOSAL FOR FOA # PAR-18-604 “Vet-LIRN Network Capacity-Building Projects” NARRATIVE This Veterinary Laboratory Investigation and Response Network (Vet-LIRN) capacity building project strengthens the capacity, collaboration, and integration of food-safety laboratories and networks, thereby facilitating an effective and coordinated response to future human and animal food safety issues. The Vet-LIRN at the U.S. Food and Drug Administration (FDA) and Animal Diseases Diagnostic Laboratory at the Ohio Department of Agriculture (Ohio ADDL) will collaborate to perform whole genome sequencing (WGS) of foodborne pathogen isolates. This project will support the identification and adoption of emerging technologies and the harmonization of analytical methods used by equipment platforms for antimicrobial resistance (AMR) studies.